Low dose ethanol effects on reward learning and motivation

Project Summary
More than half of frequent alcohol drinkers in the United States do so at a level that does not meet diagnostic
criteria for an alcohol use disorder. This chronic alcohol drinking, even at sub-diagnostic levels, can still
produce profound impacts on neurobiology and behavior. Clinical studies have shown that low levels of acute
ethanol drinking within an hour after learning can enhance task consolidation and memory recall. In contrast,
drinking before learning attenuates memory recall. Despite the prevalence of frequent, low-dose ethanol
consumption, the effects of repeated post-training ethanol on learning and the neurobiological consequences
of this level and frequency of exposure remain largely unknown. Furthermore, it is unclear whether these
effects are a result of ethanol exposure during the period of protein synthesis-dependent memory consolidation
specifically or, rather, a general outcome of post-training ethanol exposure. Our preliminary data suggest that
chronic, low-dose ethanol exposure after behavioral training increases sucrose reward-seeking behavior, while
only ethanol exposure specifically during protein synthesis-dependent consolidation enhances sucrose reward
motivation. The ventral hippocampus (vHPC) is a key structure for memory consolidation and reconsolidation.
It is further particularly sensitive to ethanol-induced disruptions, making it a likely contributor to ethanol
exposure effects on reward learning. This may be mediated by vHPC projections to the nucleus accumbens
shell (NAcS) as this circuit is critical in tracking reward value and reward-related contexts. Thus, this proposal
will test the overarching hypothesis that chronic, low-dose ethanol exposure after behavioral training impacts
reward seeking and motivation and modulates vHPC → NAcS circuit engagement. Aim 1 will combine
GCaMP6 photometry with behavioral assessment in order to test the hypothesis that chronic, low-dose ethanol
exposure enhances reward seeking and motivation, which are accompanied by alterations in vHPC → NAcS
activity. Aim 2 will use chemogenetic strategies to test the hypothesis that inhibiting vHPC → NAcS activity
during reward learning can attenuate escalations in reward-seeking behavior and motivation independent of
ethanol impacts on this circuit. The results from these experiments will expand our understanding of the
impacts of long-term low dose ethanol exposure on behavior and neurobiology, which is an area that remains
severely understudied in the alcohol use field. Further, this fellowship will enable the applicant to build on her
expertise in neural circuit regulation of alcohol use by integrating a conceptual understanding of low-dose
ethanol effects on behavior and technical training in in vivo calcium imaging in neurons. The abundance of
resources and opportunities available in the Barker lab and at Drexel University will ensure that the applicant is
prepared and qualified for a long-term career in science.

Public health relevance
Project Narrative Despite the large number of frequent drinkers who consume alcohol at levels below diagnostic criteria for an alcohol use disorder, there is a paucity of research regarding the effects of chronic, low-dose ethanol exposure on behavior and neurobiology. The proposed project will investigate the effects of chronic, low-dose ethanol exposure on reward seeking, reward motivation, and neurobiology. We will combine modern neuroscience tools with behavioral analyses to determine the role of discrete ventral hippocampus projections in motivated behavior.